Dissecting the neural stem cell state during regeneration using zebrafish and planarians

Project Summary/Abstract
The regenerative capacity of the central nervous system (CNS) is severely limited in humans and other
mammals, such that neural injury is often irreparable. Thus, damage to the CNS is a catastrophic event and
often results in permanent disability, as regenerative medicine lacks an effective strategy to overcome neural
loss. To potentially overcome this damage, new neurons are ultimately made from stem cells, yet the genetic
programs that stem cells use to regenerate lost neurons remains unknown. Understanding how damaged cells
are replaced and how new cells functionally integrate into the existing tissue is of fundamental importance in
understanding neural plasticity, and neural injury or degeneration. This proposal utilizes zebrafish and
planarians, both powerful models of CNS regeneration. First, I will use larval zebrafish to identify the factors
that define neural stem cells (NSCs) in the spinal cord that are activated in response to neural injury. I used a
single-cell RNA-sequencing approach; over 40,000 cells were sequenced in total from spinal tissue spanning a
week of recovery after injury. This dataset serves as an important guide for the experiments proposed here
because neural cells can be isolated using known markers and I have identified injury-enriched neural cell
clusters. In Aim 1, I seek to validate transcriptomic data with in vivo gene expression analysis to determine the
molecular heterogeneity of NSCs and to perform clonal analysis, using a multicolor cell labeling technique, to
understand if heterogeneous NSC populations give rise to diverse cell types. I will also use a conditional cell
ablation strategy to determine how each stem cell population is involved in spinal cord regeneration.
Experiments described in Aim 2 will investigate one candidate gene whose expression is upregulated in SCI:
cytokine receptor-like factor 1a (crlf1a). I have found that crlf1a labels a unique population of NSCs that are
potentially de-differentiated ERGs, activated in response to injury. I will determine what stem cell factors are
co-expressed in crlf1a+ cells, and I will use a conditional mutagenesis strategy to remove crlf1a from NSCs to
determine a functional role during spinal cord regeneration. Aim 3 will determine if cytokine signaling through
the ancestral receptor unit, GP130, is required for whole-brain regeneration in planarians. The findings
generated from this research will elucidate the complicated biology of stem cell lineage development in the
CNS and, in turn, impact understanding of how the neural stem cell state can instruct proper neurogenesis
following neural injury. Neural cell types are highly conserved, so we expect these findings to be broadly
applicable to human neural injuries, diseases, and therapies. The experiments, lab environment, and additional
training opportunities outlined in this proposal will present a phenomenal training experience that will enhance
my technical skillset, further develop my knowledge of stem cell biology, and allow me to carve out a research
area to lead as an independent investigator with my own laboratory.

Public health relevance
Project Narrative The regenerative capacity of the central nervous system (CNS) is severely limited in humans, making trauma such as spinal cord injury (SCI) irreparable, however, species such as zebrafish and planarians can successfully regenerate and recover from CNS injuries. Aim 1 seeks to determine the molecular heterogeneity of neural stem cells (NSCs) in the zebrafish spinal cord and use clonal analysis and cell ablation to determine the resulting lineages following SCI. Aim 2 investigates the function of a NSC subpopulation marker, the cytokine receptor crlf1a, as an injury-responsive neurogenic factor, and Aim 3 investigates a functional role for conserved cytokine receptor signaling in whole-brain regeneration using planarians.